DREAMS - National Research Core

Project Summary/Abstract: National Diabetes Policy Research (DPR) Resource Core
To promote health equity across the diabetes continuum, a new generation of translational research must
address the larger systems that generate or undermine health – from clinical healthcare systems to public
health systems to social systems. Diabetes policy research increasingly relies on methodological expertise in
five key areas: (1) natural experiments research; (2) health economics including comparative effectiveness and
cost-effectiveness analysis; (3) simulation modeling; (4) machine learning; and (5) communicating science to
policy-making institutions, community partners, health departments, and human service organizations. As
National Resource Core within the Diabetes Research for Equity through Advanced Multilevel Science Center
for Diabetes Translational Research (DREAMS-CDTR), the National Diabetes Policy Research Resource Core
(National DPR Core) will extend the reach of the CDTR expertise and resources beyond the primary
institutions by leveraging cutting-edge and robust methodologies; improving the uptake of research across
diverse focused on high-risk populations; and enhancing the efficiency, productivity, effectiveness, and
multidisciplinary nature of diabetes translation research through allocation of on-demand availability of experts
across the five key areas listed above.
The National DPR Core will draw upon the research expertise in diabetes at UCSF, UC Davis, UC Merced and
Kaiser Permanente Northern California, which together have a focus on promoting health equity among
vulnerable populations and a specific portfolio of research and translation of interventions to reduce
socioeconomic and race/ethnic disparities in diabetes prevention and treatment outcomes. These include
policies related to social and structural determinants of health such as health literacy, food insecurity, healthy
food access and sugary beverage consumption, health insurance design, access to health information
technology, and barriers to safety net clinic programs.
The National DPR Core will be dedicated solely to expanding core services to investigators and others outside
of the DREAMS-CDTR, offering collaborations between epidemiologists, economists, and health service
researchers; and facilitating linkages to community health plans, public health departments and social service
agencies for diabetes researchers.